Automated Microfluidics: Advancing Cell Culturing through Non-Sacrificial Analysis and Heterogeneous Microenvironments

SUMMARY
This STTR project aims to advance the commercialization of an innovative automated cell culturing system,
addressing drawbacks of conventional methods and comparing our technology's advantages with existing
competing products. The system integrates microscopic nozzles to enable precise fluid and cell manipulations,
overcoming challenges of maintaining heterogeneous microenvironments and sacrificial analysis. To that end,
we will demonstrate advanced capabilities that are not currently possible using conventional culturing
technologies: namely, 1) achieving a complex tissue pattern by inducing different cell lineages from stem cells
via localized drug delivery; and 2) a non-disruptive microscopy-free way to analyze different locations in the
culture in real time via micro-probing. By providing researchers with these novel tools, this project holds the
potential for transforming cell culturing, supporting a startup, and reducing reliance on animal testing, aligning
with ethical research practices.

Public health relevance
NARRATIVE This project helps to advance an innovative cell culturing system by establishing its feasibility as a market- ready product. The outcomes of this research will enhance disease research and drug testing, while launching a small business venture: AltVIVO, Inc. The technology's potential to minimize animal testing also aligns with ethical scientific practices and government initiatives aimed at reducing reliance on animal testing in research and promoting alternative methods for scientific advancement.